Mechanistic Analysis of Genetic Modifiers in Parkinson's Disease

Summary
I believe that combining disease gene discovery approaches with in-depth follow-up mechanistic and
functional studies is a unique aspect of my research program. Our recent discovery of “human-specific” pathways
and phenotypes (compared to mice) in midbrain DA neurons has led us to focus on patient-derived DA neurons
to examine the function of PD-linked genes. By employing co-cultures of iPS-derived neurons, microglia and
astrocytes, we will examine the interplay of cell-autonomous and no-cell autonomous pathways that lead to
dysfunction of midbrain DA neurons in PD. Moreover, we will use innovative technology to simultaneously
examine a large number of genetic variants in a pooled iPS approach that has not been possible previously.
Finally, our recent discovery of direct contacts between lysosomes and mitochondrial has opened a completely
new opportunity to examine inter- and intra-organellar dynamics in neurodegeneration. The R35 award would
provide me the time, freedom and stability to be even more adventurous and, as always, follow the most
interesting biology to have a high impact on the field.

Public health relevance
Project Narrative The purpose of the proposed research is to develop a platform to mechanistically examine genetic modifiers of PD in patient-derived neurons, microglia and astrocytes. We hypothesize that these glial cells normally offer protection to neurons, and we proposed to examine how this protection becomes harmful in PD. We will focus on GBA1-PD but the main idea was to develop these novel experimental approaches as a platform for other studies in PD, as well neurodegeneration more broadly.